HUMAN PROLACTIN SECRETION IN VARIOUS ENDOCRINE DISORDERS

Prolactin levels are determined in patients with pituitary dysfunction during dynamic provocative stimulation. The emphasis on patients with prolactin secreting pituitary adenomas, pre and post surgical adenomectomy.